Promoting Diverse Perspectives: Addressing Health Disparities Related to Alzheimer's and other Dementias

PROJECT SUMMARY
Alzheimer's and other dementias are primary causes of disability and dependency in the US, but do not affect
all groups equally. African Americans, American Indians/Alaska Natives, and Hispanic/Latino Americans have
higher risk of dementia than non-Latino Whites and Asian Americans. Research to understand and ameliorate
health disparities should be a public health priority, but historically few aging-related research grant awards
relate to health disparities. In response, the NIA created the Health Disparities Research Framework (HDRF),
which highlights environmental, sociocultural, behavioral, and biological factors that contribute to disparities in
age-related disease. To advance disparities research in dementia specifically, the Alzheimer's Association
(AA) will develop and hold two 2-day conferences, occurring in consecutive years (2021-22), for which all
keynote, plenary, poster and other presentations will be mapped onto the NIA HDFR. Objectives include: 1)
increase collaboration across the scientific community, 2) promote diffusion of new research designs and
analytic methods, 3) create information and mentoring bridges between senior and early career investigators,
and 4) promote more systematic research via the NIA HDRF. Each 250 in-person and 150 remotely-connected
conference will be held in Washington, DC. Conference attendance will be free, and travel and meals will be
covered for speakers and conference workgroup members. The AA will cover expenses relating to personnel,
conference meals, the professional networking reception, and basic supplies. To meet our objectives, the five
aims are: 1) Finalize the scientific program and all logistical details for the conference, via the Conference
Workgroup that developed the preliminary program. The Conference Workgroup consists of a diverse group of
AA and non-AA experts and is led by Principal Investigator, Dr. Carl V. Hill of AA. 2), Implement the
conferences, entitled “Promoting Diverse Perspectives by Addressing Health Disparities Related to Alzheimer's
and other Dementias”, consisting of lectures, panels, poster sessions, networking opportunities, and online
evaluation of the conferences. 3), Facilitate sustainability of these efforts by hosting two mid-year webinars,
highlighting developments in the field. 4), Promote the careers of early investigators via dedicated poster
sessions, mentoring/short presentation sessions, and monthly social media, “spotlights.” 5), Disseminate
conference findings and promote future research by publishing conference proceedings and special issues in
relevant journals featuring research derived from the conferences and webinars. Results will include 1)
dissemination of multi-level analyses of determinants of disparities in Alzheimer's and other dementias; 2) new
cross-disciplinary fertilization, networking and collaborations in disparities research in dementia; 3) career
enhancement for early career investigators and 4) overall advancement of dementia science toward the
discovery of new mitigating and treatment approaches for all people.

Public health relevance
PROJECT NARRATIVE Alzheimer's disease and other dementias are a primary cause of disability and dependency in the United States, but do not affect all groups equally. African Americans, American Indians/Alaska Natives and Hispanic/Latino Americans all have higher risk than non-Latino Whites and Asian Americans. This proposed conference will bring together established and early career researchers interested in better understanding environmental, sociocultural, behavioral and biological factors that contribute to disparities in dementia. This proposed conference will also catalyze career development for researchers with expertise and interest in research that addresses disparities in Alzheimer's disease and other dementias. The mix of researchers attending this conference will allow formal and informal opportunities for mentored discussions about conducting rigorous health disparities research related to Alzheimer's and other dementias.